Explaining the variability in focused ultrasound neuromodulation

PROJECT SUMMARY
While conventional electromagnetic approaches to non-invasive brain stimulation are limited in their spatial
resolution and penetration depth, ultrasonic neuromodulation carries the potential of millimeter scale
stimulation of deep brain regions without the need for surgery. Abundant evidence shows that low intensity
focused ultrasound stimulation (FUS) modulates brain activity. However, there have been several reports of
substantial variability in the neural response to ultrasound, with the same "dose" producing disparate effects.
Understanding the source of variability is critical to harnessing the vast potential of FUS in basic neuroscience,
neurology, and psychiatry.
The long term goal of this research is to develop FUS into a personalized, closed loop technology that
can drive brain activity towards desirable states. As the first step towards this goal, the overall objective of this
proposal is to identify the primary source of the variability in neuronal responses to FUS. Based on our group's
preliminary data, our central hypothesis is that response to FUS is greatly influenced by brain state, and that
the outcome of stimulation may be accurately predicted by taking into account the dynamics of neural activity
leading up to stimulation. In the proposed work, we will thoroughly test the notion that FUS is state dependent
by probing the influence of oscillatory dynamics and cell type during both sleep and wake states. Our specific
aims are: (1) Identify the relationship between baseline LFP dynamics and neuronal response during sleep, (2)
Identify the role of cell type in response to FUS during sleep, and (3) Identify the determinants of neuronal
response to FUS in the awake state. We will work with both urethane-anesthetized and head-fixed awake rats,
and will target the hippocampus with FUS while simultaneously capturing electrophysiological activity.
The proposed work is significant because it addresses the central problem with ultrasonic
neuromodulation: how to make its effects more robust and predictable. This research is innovative because it
explicitly links neural dynamics leading up to stimulation with the subsequent response to FUS.
The products of this research have the potential to solve a central problem in FUS: variability of
response. By delineating the conditions that lead to robust effects, this research will bring the FUS field one
step closer to closed-loop capabilities, which clearly necessitate predictable responses. Moreover, we will
obtain a clearer understanding of the mechanism of FUS by considering the neurobiological substrates of the
responsive states identified in this research. For example, if we do confirm a link between FUS response and
baseline gamma, this will shed light on the (gamma generating) circuits that FUS is modulating. This
knowledge will then immediately inform the rapidly growing FUS neuromodulation research community as well
as future pilot studies in neurology and psychiatry.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will accelerate the development of device-based interventions for neurological and psychiatric disorders associated with aberrant neural activity. Thus, the proposed research is relevant to the part of NIH's mission that pertains to the application of fundamental knowledge about the nature of living systems to reduce illness and disability.